Technological Assessment and Solutions Core - RC4

Project Summary: Resource Core 4 (RC4): Technological Assessment and Solutions Core
Advances in the uses of engineered technologies and AI, including electronic mobile digital health (EMDH)
technologies in health care, hold great promise for improving the older adult well-being and the care of frail
older adults. The overarching goal of the Technological Assessment and Solutions Core (RC4) is to develop a
novel ecosystem that promotes the development, testing, implementation, and dissemination of novel
technologies and new uses of artificial intelligence for frailty-related purposes. This ecosystem will be created
by bringing engineers, bioengineers, Gerontologists, Geriatricians and other clinical investigators together into
built infrastructure that facilitates the development and testing of novel approaches to health care in frailty. This
core will bridge the existing deep expertise in clinical investigation related to frailty to the deep expertise in
EMDH technologies, robotics, and AI that exists at Johns Hopkins. Examples of projects that could be
supported by this core include 1) robotic assistance with medication 2) treatment adherence the development
of novel mobility and fall prevention technologies, 3) measurement improvements in frailty diagnostics through
technology-assisted measurement of gait, activity, and other functional signals; 4) leveraging AI to build frailty
assessments from these signals are also envisioned, and 5) remotely deployed technological interventions and
measurement modalities could provide rich opportunities to expand reach to underserved older adults. This
resource core, in collaboration with RC1, 2, and 3, proposes to support 2 pilot studies in this proposal. The
specific aims of RC4 are: 1) to provide state-of-the-art engineering and technology application expertise to
facilitate and support a broad array of translational frailty research; 2) to provide access to relevant
technologies, and the necessary infrastructure to study frailty; 3) to facilitate the translation of RC4 frailty-
related and focused technologies and uses of AI into intervention- or prevention-focused clinical studies in
collaboration with the leadership of other resource cores; 4) to provide training, mentorship, and guidance to a
diverse group of the most promising junior investigators who can contribute to frailty research, and to assure
that RC4-developed technology are accessible to underserved populations of older adults; 5) To provide
access to business development as relevant and local and national visibility for RC4-related science and
activities.